Non-invasive Biomarkers of Symptom Severity and Treatment Response in Pediatric Feeding Disorders

PROJECT SUMMARY
Pediatric feeding disorders are extremely common, affecting 5-20% of children, and they cause
significant patient morbidity, decreased quality of life for children and parents, and increased healthcare
utilization and cost. Many of these patients require feeding tube placement, but even this does not ensure
successful feeding and growth. Up to 50% of children with gastrostomy tubes suffer from feeding intolerance,
defined as vomiting or inability to tolerate adequate feed volumes to sustain growth. Despite the high
prevalence and large health impact of this problem, no prospective studies exist to help inform management.
Furthermore, the gastrointestinal mechanisms underlying feeding intolerance remain largely unknown,
hindering our ability to effectively target treatments toward patient pathophysiology.
Two proposed mechanisms of feeding intolerance are (1) delayed gastric emptying and (2) impaired
gastric accommodation. We have shown that 49% of children with feeding intolerance have delayed gastric
emptying; however, no studies have correlated delayed gastric emptying with feeding intolerance symptoms or
assessed the role of other abnormalities of gastric physiology such as impaired accommodation. In Aim 1 of
this proposal, we will use a cross-sectional study design to fully characterize (using both ultrasonography and
scintigraphy) gastric emptying and accommodation patterns in gastrostomy-fed patients with and without
feeding intolerance. In Aim 2, we will use a prospective cohort design to assess changes in gastric physiology
and feeding intolerance symptoms after initiating therapy with erythromycin (which improves gastric emptying)
or cyproheptadine (which improves gastric accommodation).
Dr. Suzanna Hirsch, MD is an Instructor at Harvard Medical School (HMS) and a subspecialist within
the Aerodigestive Center at Boston Children’s Hospital (BCH). She has gained substantial clinical research
experience during her medical training and has demonstrated commitment to an academic career in patient-
oriented research. Her career goal is to fundamentally advance scientific understanding of gastric dysfunction
in pediatric feeding disorders and to use this mechanistic knowledge to drive evidence-based care and fuel
treatment innovation. The mentorship and training afforded by this career development award will be critical for
Dr. Hirsch’s academic development. Her primary mentor, Dr. Rachel Rosen, is an expert in pediatric motility
disorders, and her co-mentor, Dr. Odd Helge Gilja, is an expert in gastrointestinal ultrasonography – both are
exceptional researchers with longstanding commitments to mentorship. Dr. Hirsch has carefully crafted a
career development plan with opportunities to gain skills in gastric ultrasonography and clinical research
methods. She will pursue a Master’s in Public Health including coursework in repeated measures, longitudinal
data analyses, and clinical trial design. Her research activities will be conducted in the unparalleled academic
environments of BCH and HMS, which are firmly committed to her successful transition to independence.

Public health relevance
PROJECT NARRATIVE Up to 50% of children fed by gastrostomy tube suffer from feeding intolerance but, despite the high prevalence and large health impact of this issue, little is known about its pathophysiology, which hampers our ability to deliver personalized, physiology-based therapies. We hypothesize that patients with feeding intolerance have measurable impairments in gastric emptying and accommodation and that non-invasive biomarkers can be identified that are associated with symptom severity and treatment response. Through this career development award, we will use both cross-sectional and longitudinal cohort study designs to: (1) thoroughly characterize gastric mechanisms of feeding intolerance using gastric ultrasonography and nuclear medicine scintigraphy and (2) quantify the physiologic and clinical impacts of two commonly used but inadequately studied feeding intolerance treatments, erythromycin (which improves gastric emptying) and cyproheptadine (which improves gastric accommodation).